ACTG 243--PML STUDY

The purpose of this study is to try to establish which of three treatment method reported by some investigators to result in stabilization or improvement in Progressive Multifocal Leukoencephalopathy (PML), a fatal viral infection of the nervous system, is most effective.